INTERNAL FUSION PEPTIDE OF THE SEVERE ACUTE RESPIRATORY SYNDROME CORONAVIRUS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We have initiated a study of lipid interactions of a synthetic peptide corresponding to the internal fusion peptide from SARS-CoV (IFP18). Fusion peptide can be classified as an N-terminal or internal, depending on their location relative to the cleavage site of the viral fusion protein. The coronavirus spike protein (S) protein is known to be cleaved at the S1/S2 boundary. This cleavage site is not closely linked to a fusion peptide. It was reported that a synthetic peptide, consisting of 18 resides, immediately C-terminal to a second S2 cleavage site of SARS-CoV (IFP18), promotes lipid mixing. Mutagenesis studies showed that some conserved residues in this sequence of SARS-CoV are critical in viral fusion mediated by SARS-Cov. Thus, this peptide was suggested to be an internal fusion peptide [1]. [1] Madu, I.G., S.L. Roth, S. Belouzard, and G.R. Whittaker. 2009. Characterization of highly conserved domains within the severe acute respiratory syndrome coronavirus spike protein S2 domain with characteristics of a viral fusion peptide. J. Virol. 83:7411-7421.